Chemoenzymatic Semisynthesis of Proteoglycan and Its Cofactor Activities

Project Summary/Abstract
Thrombomodulin (TM) is a proteoglycan expressed on the surface of vascular endothelial cells and
contributes to vascular haemostatic balance. TM serves as a cofactor for thrombin-mediated activation of
both protein C and thrombin activatable fibrinolysis inhibitor (TAFI), which alter thrombin specificity from
procoagulant toward anticoagulant and antifibrinolytic pathways. It is acritical question whether protein C
and TAFI compete for TM/thrombin complex. Earlier study with soluble TM found that protein C and TAFI
competitively bind to TM/thrombin complex in solution, but later study of endothelial cells found that
protein C and TAFI do not compete each other. Interestingly, our recent study with liposomal TM found a
lipid-dependent competition between protein C and TAFI for the thrombin/TM complex. These results
indicate that membrane lipids affect protein C and TAFI activation. Therefore, whether and how these
two physiologically important events are either independently or cooperatively regulated in the
vasculature deserve to be filly elucidated. TM is a proteoglycan with chondroitin sulfate (CS)
glycosaminoglycan (GAG) on its serine-threonine rich region. TM CSGAG can be involved in thrombin
binding via it’s exosite II and protein C activation. However, whether the TM CSGAG is involved in TM’s
TAFI activation and its role in regulation of protein C and TAFI activation are remain uninvestigated so far.
TM is a membrane proteoglycan, membrane lipids in TM cofactor activities is of significant interest.
Liposomes, in which lipid composition closely resembles that of cell membranes, have been extensively
studied as cell membrane model for studying membrane protein function and drug delivery application.
Therefore, we propose a recombinant TM/CSGAGA-liposome conjugate, which mimics the native
endothelial TM and lipid components and will be useful tool to study TM’s protein C and TAFI activation.
Three specific aims will be investigated: Aim 1. Synthesizing recombinant TM-CSGAG conjugates and
investigating CSGAG’s role in protein C and TAFI activation, Aim 2. Synthesizing recombinant TM-
liposome conjugates and investigating lipid effect on protein C and TAFI activation, Aim 3. Synthesize
recombinant TM/CSGG-liposome conjugates and investigating CSGAG and lipid effect on protein C and
TAFI activation. The engineered membrane mimetic platform with TM domains and defined CSGAG will
permit a renewed understanding of both CSGAG’s and lipid’s role in TM cofactor activities. Broadly, this
strategy will provide a new tool for functional studies of membrane proteoglycan and glycoprotein of any
kind.

Public health relevance
Project Narrative Thrombomodulin (TM) is a transmembrane proteoglycan expressed on vascular endothelial cells and contributes to vascular haemostatic balance by serving as an essential cofactor for the activation of both anticoagulant and antifibrinolytic protein. This project aims to develop a comprehensive approach for studying TM proteoglycan structure and anticoagulant and antifibrinolytic activity relationship and thus will provide potential insight for the development of novel therapeutics.